Scalable high-plex pipeline for whole-brain proteomics profiling

Abstract
Knowing the molecular signature of distinct brain cell types in the human brain is relevant for basic
neuroscience research and understanding neurological disease. While past and ongoing large-scale
scRNAseq and spatial transcriptomics efforts have provided a comprehensive mRNA expression atlas,
there lacks a similar proteomics atlas due to the limited profiling throughput of current methods.
Additionally, studies have shown expression discrepancy between the transcription and translation levels,
especially during development. Therefore, mapping proteomes, not just transcriptomes, is crucial to
providing a comprehensive understanding of the cell-type molecular signatures. Current methods to
profile the proteome have disadvantages such as low multiplexity, slow acquisition speed, and high data
storage costs. We propose improving upon these current methods by increasing multiplexity with a 100-
plex antibody panel, increasing acquisition speed with the creation of a novel ultra-speed light-sheet
microscope and data management system, and lowering storage costs by implementing high-fidelity
lossy compression. Finally, we will implement this scalable strategy to generate 100-plex proteomic
atlases of the whole mouse brain across 6 postnatal stages.

Public health relevance
Narrative Identifying distinct cell types and their molecular signatures is crucial for advancing neuroscience research and determining the cause of mental health and neurodegenerative diseases. In order to overcome current technology barriers that prohibit our comprehensive understanding of cell type development across the entire brain, we will develop a strategy to permit rapid and cost-efficient profiling of 100 protein cell type markers throughout the whole mouse brain across 6 postnatal stages. The success of this project will establish the baseline of neuronal cell type differentiation in postnatal mouse development for future discoveries of abnormalities in various brain disease models.